Duke Population Research Center

Overall: Summary
In the ten years since its first NICHD award in 2009, the Duke University Population Research
Center (DPRC) has grown into a vibrant, interdisciplinary research organization bringing
together scientists from the social and behavioral sciences and the biological, health, and
statistical sciences at Duke. We now have a network of population scientists whose interests
encompass health and well-being over the life course and extend to primate species as well as
humans, or who use social network analysis to model health, human development, and
demographic outcomes. New population science at DPRC is being generated by established
and early career scholars with diverse disciplinary backgrounds who have taken advantage of
the services of the Development Core to launch new, successful projects. DPRC's impact is
greatest in two primary research areas: (1) Foundations of Lifelong Health, and (2)
Interconnected Social Systems and Population Health. In pursuit of these questions, we
facilitate and promote (a) longitudinal data collections that follow cohorts from childhood and
reach across generations; (b) innovative data collection that rely on social connectivity to recruit
rare and hidden population samples or to map complete population networks; (c) the utilization
of linked administrative data that lengthen, broaden and deepen the view of life course health
and human development processes; and (d) the development of new tools and approaches for
“big” population and health science. This application requests renewal funding from the NICHD
Population Dynamics Centers Research Infrastructure (P2C) to support three cores—
administration, development and science. The proposed cores will lower administrative costs
while providing tools and technical support to create synergies and efficiencies in seeking,
securing and managing external funding that will free up and enable DPRC scholars to
concentrate on science. Our goal is to continue to increase external funding to develop science
that would not be possible without DPRC, by taking advantage of: (a) the number and quality of
population researchers at Duke; (b) our successful record of developing the next generation of
population scientists; (c) our unique data resources; (d) our proven track record of rigorous, high
impact science; (e) our collaborations with local and international academic institutions and
regional government partners to accelerate the impact of population studies on policy and
society.

Public health relevance
Project Narrative -- The Duke Population Research Center (DPRC) provides an adaptive scientific infrastructure to promote the collaborative, interdisciplinary study of the trajectories of healthy child development and lifelong health, by bringing together scientists from multiple disciplines, who are interested in the frameworks for measurement, classification and data collection which are anchored in the core concepts of demography and population sciences.